Amino acid mimicry: Insights into glyphosate transport and toxicity to mitochondria

Extensive use of glyphosate-based herbicides (GBH) has led to glyphosate entering the food chain, and
causing human sera and urine levels to increase over time. This exposure has led to numerous claims that
glyphosate causes diseases ranging from multiple types of cancer to affecting human development and
reproduction. However, no mechanism of glyphosate import into human cells is known; in yeast, importation
occurs through the glutamate/ aspartate (D/E) transporters due to its structural resemblance. Glyphosate is
thought not to have acute effects on humans because they lack the shikimate pathway that produces aromatic
amino acids (WYF), which is inhibited in the presence of glyphosate, and humans instead acquire aromatic
amino acids through diet or the gut microbiome. The differences in commercial preparations of glyphosate
have complicated the studies because GBHs have surfactants that increase tissue penetration. Yeast can
bypass the inhibition of the shikimate pathway when supplemented with (WYF), which permits the assessment
of the role of surfactants or, more likely, discover the unknown glyphosate targets. Our initial studies have
found that genes regulating mitochondria, DNA damage, and the cell cycle are differentially regulated in GBH
treatments. The long-term goal is to identify the glyphosate transportation mechanisms into cells, the brain,
and other tissues that affect mitochondrial metabolism. This application's objective is to determine how
mitochondrial metabolism is affected by glyphosate alone and in commercial formulations in the model
organism S. cerevisiae. Our central hypothesis is that the transport of glyphosate is due to mimicry of
glutamate and aspartate; thus, it will affect other enzymes that utilize glutamate and aspartate, especially
within the mitochondria. The rationale of this proposal is that mitochondrial effects of glyphosate have a
biochemical basis and will provide a mechanistic understanding of cellular effects in vertebrate species.
Specific aims proposed are 1. Measure the import of glyphosate into different compartments in different
mutants and how adding D/E rescues growth inhibition from glyphosate 2. Measure changes in specific
mitochondrial metabolites (ATP and NADH) in glyphosate treated cells. The proposed research is innovative
because the hypothesis proposed is using unbiased experiments, such as genome-wide association,
transcriptomics, and In-Lab Evolution experiments to determine the mechanism of extra- and intracellular
glyphosate transport using D/E transporters. Glyphosate mimics D/E amino acids in transport, so it likely
affects other enzymes that use D/E, particularly in the mitochondria. In plants, fungi, and bacteria, D/E
transporters have all been implicated in glyphosate transport and glyphosate affecting mitochondrial functions.
While humans do not have the shikimate pathway, they have D/E transporters, and conserved mitochondrial
proteins that use D/E, which may be the off-targets of glyphosate leading to the range of diseases claimed to
have been caused by glyphosate.

Public health relevance
Project Narrative Understanding how chemical exposure affects organisms provides insight into understanding basic cellular metabolism, as well as paving the way for the treatments of neurological diseases and metabolic disorders. The glyphosate’s (the active ingredient in a popular herbicide) effects on cellular metabolism have hinted at mitochondrial targets but the mechanism is not known yet based on how it’s imported into cells it’s likely affecting enzymes that use glutamate and aspartate. Using S. cerevisiae, brewer’s yeast, as a model, we will determine how pure glyphosate and commercial preparations change mitochondrial function allowing for future studies on affected organs in humans.